Cancer Center Administration

Abstract Cancer Center Administration
The City of Hope Comprehensive Cancer Center (COHCCC) Administration provides effective and efficient
administrative support to facilitate COHCCC strategic and operational priorities.
During the current funding cycle, Administration was re-organized to strategically enhance its support of
COHCCC priorities and address review critiques. A now fully integrated and realigned Administration is led by
an experienced Associate Director for Administration (ADA), Ms. Ashley Baker Lee. Administration has
expanded and now includes four additional senior managers to better facilitate the basic, clinical, translational,
and population-based research and education mission of the COHCCC. Through this integration and expansion,
the role that Administration now plays has grown considerably to ensure COHCCC and Cancer Center Support
Grant (CCSG) needs are represented, prioritized, and aligned in an effective manner
Administration facilitates COHCCC strategic priorities, oversees all COHCCC programmatic activities, and
promotes collaborative multidisciplinary and transdisciplinary translational research by integrating basic,
translational, population-based, and clinical research as well as training activities across the COHCCC.
Administration is also responsible for coordinating all COHCCC research administrative and strategic functions
in pursuit of COHCCC’s mission. Administration ensures COHCCC adherence to all CCSG expectations and
guidelines from proposal stage through reporting. Administration supports key COHCCC functions such as space
management, Shared Resources business support, financial management, faculty recruitment/retention,
meeting/seminar facilitation, pilot program management, membership activities, connections to central offices,
communications, and strategic planning/evaluation support.
Evidence of impact of Administration includes successful recruitment and onboarding of 48 new COHCCC
Program Members; development and endorsement of a new COHCCC strategic plan; expansion of laboratory
research space through purchase/renovation of a 141,000 sq. ft. building; and implementation of multiple IT
systems in support of research, including Epic and OnCore.